Administrative Core

PROJECT SUMMARY
The overall objective of Emergency Departments LEading the transformation of Alzheimer’s and Dementia
care (ED-LEAD) is to optimize and study a suite of care interventions (emergency care redesign, nurse-led
telephonic case management, and community paramedic-led transitions intervention) both alone and in
combination, in a pragmatic, multifactorial trial embedded in 80 Emergency Departments (EDs). The overall
goal is to decrease emergency department use and hospitalizations, and increase days at home for persons
living with dementia (PLWD) and for their care partners (collectively known as dyads), who visit the ED. The
primary roles of the Administrative Core are to: 1) ensure efficient and effective communication between
interventions, cores, and ED sites; 2) coordinate support and guidance from external partners; and 3)
disseminate products and findings of this work. In particular, the Administrative Core leadership will mobilize
expertise from two NIA-funded dementia research networks in emergency medicine and pragmatic trials, and
convene an External Advisory Board comprising organizational stakeholders, a Lived Experience Panel made
up of PLWD and care partners, and a Lived Practice Panel comprising different disciplines engaged in
intervention experience. All three groups will provide insights critical to the success of ED-LEAD. The
Administrative Core will be led by a Steering Committee comprising the Executive Director, the multiple PI
(mPI) team (Chodosh, Brody, Shah, and Grudzen), Statistical Core Lead (Goldfeld), Lead Informatician
(Mann), and NIA project scientists. These seasoned collaborators will be supported by a rich research
infrastructure and personnel with expertise in launching complex interventions across multiple settings in older
adults with serious illness. NYU Grossman School of Medicine, NYU Rory Meyers College of Nursing,
University of Wisconsin–Madison School of Medicine and Public Health, Memorial Sloan Kettering Cancer
Center, and the mPI team have substantial expertise in tailoring the electronic health record (EHR) to promote
EHR interoperability and using single IRB review to increase efficiency of multi-site embedded pragmatic trials.
As a first step to ensuring effective and efficient functioning across the three interventions, the Administrative
Core will classify and catalogue intervention core functions and clinical decision support processes into forms
for ongoing reference and to preserve knowledge for future use. Besides financial management, the
Administrative Core will recruit, engage, guide, and support the External Advisory Board, and the Lived
Experience Panel and the Lived Practice Panel. The Administrative Core will integrate expertise from NIA-
funded dementia research networks, all in close coordination with the Implementation Core, and direct all
processes to support a strong communication plan. This includes developing and maintaining an accessible
and robust website and using various forums to disseminate knowledge.